Role of miR-181a-5p in Adenovirus 14p1 induced Acute Lung Injury

PROJECT SUMMARY
There have been globally distributed, regional outbreaks of a novel strain of adenovirus (Ad) 14, Ad14p1,
that induces acute lung injury similar to that observed during outbreaks of infections with other Ad serotypes
(e.g., Ad 3, 4 and 7). It has not, however, previously been possible to do comparative virology and pathogenesis
studies, contrasting a prototype, parental Ad strain, such as Ad14, with a single, globally distributed genetic
variant, such as Ad14p1.
The reasons for the increased severity of these Ad14p1 infections are poorly defined. We have shown that
cells undergoing Ad-induced cytopathic effect (CPE) from infection with Ad14 elicit an immunorepressive activity
of activated human alveolar macrophages by repressing IL-1b, IL-6, IL-8 and TNF-alpha. In contrast, Ad14p1
CPE corpses enhance production of these same cytokines, due to decreased expression of viral E1B 20K in
Ad14p1 CPE corpses. Consistent with these in vitro observations, infection of Syrian hamsters with prototype
Ad14 resulted in minimal inflammation and lung injury, whereas Ad14p1 infection induced a marked acute lung
injury and ARDS-like pathology.
It has been shown that apoptotic cells have altered expression of microRNA (miRNA) that can repress pro-
inflammatory responses and that these miRNA from apoptotic cells can be delivered to macrophages. We
postulated that a similar mechanism could be occurring with Ad14 infected cells but not cells infected with the
Ad14p1 variant. To test this, we infected human cells with Ad14 or Ad14p1 and did small RNA-seq on the
respective CPE corpses. The data showed that Ad14 CPE corpses are enriched in four miRNA (Ad14 miRNA),
all of which have been shown to repress NF-kB dependent transcription of pro-inflammatory cytokines, compared
to Ad14p1 CPE corpses. Our hypothesis is that increased expression of these specific miRNA in Ad14 CPE
corpses and their transfer to responder macrophages are the mechanisms through which Ad14 CPE corpses
repress pro-inflammatory responses.
The studies we propose here will test those hypotheses. We will test the role of Ad14 miRNA in modulating
inflammatory responses of macrophages using miRNA mimics and whether E1B 20K modulates Ad14 miRNA
expression during infection. We will test the role of the most abundantly expressed Ad14 miRNA, miR-181a-5p,
as the mediator of Ad14 CPE immunorepression by using 3’ UTR reporter constructs and inhibiting miR-181a-
5p with miRZips. Finally, we will do translational studies to determine the role miR-181a-5p plays in the
immunopathogenesis of Ad14p1 infection in the Syrian hamster. Upon completion of this project, we expect to
have an increased understanding of the role of virally induced cellular miRNAs in modulation of macrophage
responses during acute lung injury in response to Ad14p1. The positive impact of our studies will be the
determination of the potential of miRNAs as therapeutic interventions for ARDS.

Public health relevance
PROJECT NARRATIVE Human adenovirus (Ad) infection can cause acute lung injury and acute respiratory distress syndrome (ARDS), with few treatment options for infection-induced ARDS, that has a fatality rate approaching 40%. Alveolar macrophages (AM) in the lung are key players in the inflammatory response leading to ARDS. Cells dying from Ad14 repress AM inflammatory responses, whereas cells dying from infection with emergent Ad14p1 do not. The objective of this proposal is to understand how alterations in host miRNA expression regulates AM inflammatory responses to Ad-infected cells and assess the ability of microRNA to serve as a therapeutic option to mitigate the immunopathogenesis of Ad14p1, using our Syrian hamster model of Ad-infection-induced lung pathology.